Center for Molecular Epidemiology

ABSTRACT
The field of epidemiology has gained increasing prominence in the research community and became a
household word in 2020. Epidemiology provides the tools to uncover the underlying causes of human illness
and to, in turn, inform clinical practice and preventive strategies, advise policy and regulatory actions, and
move scientific advancements forward. In Phases I and II, our Centers of Biomedical Research Excellence
(COBRE) Center for Molecular Epidemiology at Dartmouth has effectively advanced research in the field. As
the only Center for molecular epidemiology in northern New England and one of the only COBRE programs
with this focus nationally, we have successfully recruited and mentored the next generation of independent
early career investigators. We further supported established investigators to enlarge their research programs,
form new collaborations and integrate the latest biomedical discoveries, innovations, and methods. In doing so,
we dramatically grew our research productivity and grant portfolio, as evidenced by the steep rise in the
number of publications, presentations, and grants awarded since the inception of our COBRE Center. As part
of achieving sustainability, we formed a new Department of Epidemiology and developed innovative cross-
disciplinary training grants.
Our cohesive Center brings together talented investigators focusing on 1) applying new scientific discoveries
and technologies to address major human health concerns, 2) identifying early indicators of disease
pathogenesis, and 3) exploring common pathways of disease etiology and progression in human populations,
including those related to health inequities. In this Phase III application, we will progress our molecular
epidemiology research infrastructure forward to full independence and sustainability. Specifically, we will 1)
evolve a state-of-the-art Biorepository and Biospecimen Resource Facility Core that supplies the critical
services responsive to the ongoing and future needs of biomedical scientists, 2) expand the pipeline of
talented, diverse molecular epidemiologists, and provide the requisite mentorship, career development, and
research resources to cultivate cutting-edge research and make investigators competitive for NIH funding, and
3) enhance the governance structure, implementation approaches, stakeholder engagement, and evaluation
that will strengthen our Center’s impact, promote its strategic vision, and forge ties with regional and national
partners. Our success in Phases I and II, combined with strong institutional support, positions us to serve as a
vital resource in molecular epidemiology for Northern New England, for COBRE and IDeA Networks of
Biomedical Research Excellence (INBRE) programs, and more broadly.

Public health relevance
NARRATIVE We propose to continue an impactful biomedical research center to foster investigations applying cutting-edge innovations to illuminate the causes of human disease occurrence and progression. As such, our Center has the potential to change policy and practice and to reduce disease burden throughout the life course. Our COBRE Center for Molecular Epidemiology provides a unique and critical resource from which to grow the next generation of scientists as well as advance more senior investigators within Dartmouth, with regional partners, and across molecular epidemiology more broadly.